HHSN261201400039C;SBIR TOPIC 326 DEVELOPMENT OF NOVEL THERAPEUTIC AGENTS THAT TARGET CANCER STEM CELLS;PROJECT TITLE: TARGETING BREAST CANCER STEM CELLS WITH PG-101;CONTRACT PERFORMANCE PERIOD 09/12/2

Targeting Breast cancer stem cells with PG-101